Core D: Research Support Core

Project summary: Research Support Core-I (Multi-omics Core)
Our established Research Support Core 1 (RSC 1) is a comprehensive facility that offers advanced quantitative
analytical technology platforms for metabolomics, epigenomics, transcriptomics, and proteomics. Dr. Nagireddy
Putluri serves as the RSC leader, as well as the director of Metabolomics Core, and is highly regarded in the
field of multi-omics. The RSC has four specific aims which enable integration within our BCM-Rice SRP to
comprehensively support all four Projects, work with our Cores, and provide opportunities for trainee
engagement. The RSC will provide state-of-the-art multi-omics technologies to effectively assist the BCM-Rice
SRP projects. The Core leverages the Advanced Technology Cores at Baylor College of Medicine to ensure
access to targeted and unbiased metabolomics, proteomic profiling through mass spectrometry, antibody-based
reverse phase protein array (RPPA), genome sequencing, transcriptomics using RNA-seq, as well as specialized
metabolomics, and proteomics. RSC support includes intellectual input from faculty-level Core Directors for
consultation and experimental design, hosting advanced instrumentation, performing advanced analytical
procedures by Core research staff, and processing and analyzing "omics" data sets. We further aim to develop
technological methods in direct response to the needs of our Project Leaders. RSC-I will collaborate with project
investigators to develop, validate, and implement innovative methods that are not currently standard procedures
within RSC-I. This includes the identification of novel PAH metabolites through mass spectrometry, unbiased
metabolomics profiling, epigenetic profiling of histone modifications and chromatin modifying enzymes using
RPPA, ChIP-seq for genome-wide DNA binding site identification, and characterization of the placental proteome
using gel-free proteomics with high-performance liquid chromatography-mass spectrometry (HPLC-MS)
employing isobaric tandem mass tags (TMT) technology. Furthermore. RSC-I aims to identify novel targets by
characterizing key pathways. This involves investigating the molecular mechanistic and genetic aspects of PAH
exposures through cutting-edge technical solutions, ultimately facilitating a deeper understanding of PAH
exposures at various levels. In collaboration with the RETCC, RSC-I is committed to providing training in
metabolomics, transcriptomics, and proteomics for our SRP research trainees. The ultimate goal of RSC-I is to
provide the SRP investigators with the best quality scientific solutions available, enabling them to comprehend
PAH exposures at the molecular mechanistic and genetic levels.

Public health relevance
Narrative: Research Support Core-I (Multi-omics Core) Our established Research Support Core 1 (RSC 1) is a comprehensive facility that offers advanced quantitative analytical technology platforms for metabolomics, epigenomics, transcriptomics, and proteomics. RSC-I has four specific aims which enable integration within our BCM-Rice SRP to comprehensively support all four Projects, work with our Cores, and provide opportunities for trainee engagement, providing state-of-the-art multi-omics technologies to effectively assist the BCM-Rice SRP projects.